Next Generation MRI for Virtual Mechanical Testing of Bone Fracture Healing

Bone fractures are common injuries that impact an estimated 9.6 million Americans each year, resulting in
1.6 million years of living with disability. There is currently a lack of reliable biomarkers that can detect
problems with bone healing early, which represents a major barrier to improved care. This proposal describes
a translational validation study of next generation methods for fracture diagnostics. In the study, we will use
ultrashort echo time magnetic resonance (UTE-MRI) sequences and finite element (FE) based virtual
mechanical testing to quantify and predict bone healing. Tibial fractures will be employed as a test bed for
more global applications. Our central hypothesis is that the structural quality of bone healing can be measured
using MR-based virtual mechanical testing. The study will consist of 3 Aims. In Aim 1 we will establish MR
assessment of callus mechanical properties. We will use an ovine tibial osteotomy model, fixed by
intramedullary (IM) nailing. UTE-MRI will be used to construct FE models and in situ inverse optimization will
define the mechanical properties of callus by matching the virtual mechanical tests to the postmortem physical
biomechanical tests. We hypothesize that UTE-MRI measures of bone density will be negatively correlated
with callus elastic modulus, and that image-based modeling from UTE-MRI can reliably replicate bench tests of
healing long bones. In Aim 2, we will predict late fracture healing using early MR scanning in the same ovine
model. Here, we will use MR to measure the earliest stages of repair and predict the later formation of
mineralized callus in normal and delayed healing animals. We hypothesize that the sigmoid functional recovery
curve of mechanical rigidity in delayed-healing fractures is significantly different from the recovery curve that
characterizes normal healers. In Aim 3 we will deploy MR-based virtual mechanical testing to measure fracture
healing in a clinical setting. In this observational pilot study, we will recruit 50 patients with tibial shaft fractures
treated by IM nailing. Results from 6-week UTE-based virtual mechanical testing will be correlated with 12-
week CT and MR measures and time to clinical union. Receiver-operator characteristic analysis will be used to
identify the diagnostic cutpoint for early image-based virtual mechanical testing that best discriminates
between normal healers and patients who experience delayed union (>20 weeks). We hypothesize that MR
scanning can replicate the results of CT-based virtual mechanical testing for assessment of fracture healing in
a clinical setting and that soft callus formed by 6 weeks predicts clinical outcomes (binary classification: union
or delay). This project will demonstrate how objective measurements of bone healing using radiation-free MR
imaging will fundamentally shift fracture research and clinical care paradigms by enabling an early and
proactive approach to the management of high-risk fracture patients. Our findings will lead to future
applications focused on femoral shaft fractures, fragility fractures, pediatric fractures, and limb salvage.

Public health relevance
NARRATIVE Delayed bone fracture healing and nonunions lead to high medical care costs, long-term pain, increased risk of mortality, and have the potential to lead to opioid abuse. In this study, we will use magnetic resonance imaging and computer modeling to track bone healing over time. Results from an animal model (sheep tibial osteotomy) and an observational clinical study (human tibial fractures) will be used to assess the efficacy of this new tool that can improve the care of bone fractures.